Vagal airway sensory nerve activation by beta-coronavirus spike protein

PROJECT SUMMARY
Activation of sensory nerves, in particular nociceptive C-fibers, is a feature of most respiratory
viruses. Evidence of such activation is found in the classical consequences of C-fiber activation
including sneezing, sore throat, coughing, and reflex secretions. As well as causing the troubling
symptoms of viral infection, the activation of these nerves allows viruses to escape the body and be
transmitted to other hosts, i.e. nociceptor activation amplifies viral spread in a community. In addition,
activation of airway vagal C-fibers can lead to strong reflex bronchoconstriction and excessive
secretions that likely contribute to the exacerbation of asthma particularly in children. Given the
relevance to human disease, surprisingly little is known about how virus infection induces C-fiber
activation and sensitization. In theory, viral infection leads to C-fiber activation by two general
mechanisms. The first is that viral infection of epithelial cells leads to the production of a mediator(s)
that stimulates the C-fiber terminals. The second is that the virus itself directly activates the nerves.
This second mechanism will likely be dependent on the specific virus type. This proposal focuses on
this second (direct) mechanism of activation as it relates to coronaviruses. I hypothesize that the
coronavirus spike protein interacts directly with C-fiber terminals in a manner that activates and
sensitizes the nociceptive C-fibers. My preliminary data, using three orthogonal approaches, support
the conclusion that the spike protein directly activates (evokes action potential discharge) about 40-
50% of vagal C-fibers in mouse airways. My first aim is to characterize the subtype of vagal C-fibers
that are activated by spike protein and also to assess whether the spike protein, short of overt
activation, leads to the sensitization of C-fiber terminals, i.e. renders them more sensitive to other
activating stimuli. My second aim focuses on the mechanism. I hypothesize that this interaction
involves the galactin-3 fold in the spike protein, and occurs independently of the spike protein
receptor ACE2 or toll-like receptors. Irrespective of the proximal binding target, I will address our
hypothesis that activation is secondary to the opening of TRPV1 and or TRPA1 channels. These aims
will be addressed using single cell RT-PCR analysis of mRNA expression in airway specific
nociceptive C-fibers, extracellular and patch-clamp electrophysiology, and 2-photon live imaging
techniques. The results of the studies are expected to provide insights into a novel mechanism of
coronavirus induced airway C-fiber activation.

Public health relevance
PROJECT NARRATIVE Respiratory viruses cause strong activation of sensory C-fibers, which in turn causes sneezing, coughing, and secretions. It is also likely that the activation of C-fibers contributes to reflex bronchoconstriction in children with asthma and the exacerbation of their disease. Since little is known about the mechanisms by which respiratory viruses lead to C-fiber activation, we will address the hypothesis that, with regard to coronaviruses, activation is partially mediated by direct interaction between the viral spike proteins and C-fiber terminals in the airway mucosa.